Lymph node targeting nanoparticles for HIV Env proteins

PROJECT SUMMARY
With the advent of highly successful antiretroviral therapy, mortality and morbidity associated with human
immunodeficiency virus (HIV) infection has been significantly reduced. Despite this, hundreds of thousands of
new HIV infections occur each year, demonstrating the need for a safe and effective vaccine. HIV vaccines
based on the elicitation of broadly neutralizing antibodies (bNAbs) are at the forefront of HIV research. Stabilized
HIV immunogens have now shown the ability to elicit tier 2 neutralizing antibodies in rhesus macaques, and
numerous bNAbs have been isolated from human subjects. Furthermore, germline targeting immunogens have
demonstrated initial success in humans in eliciting bNAb germline precursors. A key aspect in the effectiveness
of HIV immunogens is the delivery method. Somatic hypermutation is a critical event for optimal and efficient
bNAb elicitation. Recombinant HIV Env proteins are poorly immunogenic and fail to follow typical lymph node
(LN) trafficking pathways due to high glycosylation and poor recognition by natural IgM. Instead, recombinant
HIV Env proteins are captured by interfollicular macrophages rather than by macrophages in the subcapsular
sinus, leading to poor antigen availability and limited repeated somatic hypermutation. The scientific premise
for this proposal is that since recombinant HIV Env proteins have altered LN trafficking, biodegradable LN
targeting nanoparticles that facilitate transfer of soluble HIV Env trimers directly to LNs are a promising tool to
circumvent current barriers. Our objective is to test the hypothesis that a lymph node (LN) targeting nanoparticle
(NP) technology will improve immune responses generated by human immunodeficiency virus (HIV) envelope
(Env) protein immunogens. This proposal is high risk, as the elicitation of broadly neutralizing antibodies
(bNAbs) at a high titer and long duration is challenging; nonetheless, if successful, it offers high reward by
substantially improving HIV Env vaccine responses. In Specific Aim 1, we will determine if PLGA-b-PEG NPs
more efficiently deliver germline targeting immunogens to LN follicles and increase somatic hypermutation
compared to unencapsulated immunogens. Mice will be immunized with germline targeting immunogen trimers
encapsulated within the NP platform, and serological and cellular analysis will be completed, including monitoring
of somatic hypermutation using single cell sequencing approaches. LN trafficking and accumulation in follicles
will also be assessed. In Specific Aim 2, we will determine if co-encapsulation of diverse HIV Envs in NPs
enhances elicitation of tier 2 neutralization breadth. HIV Env SOSIP trimers from two viral clades will be combined
in a single NP, and serological responses will be assessed. This proposal is highly collaborative, combining Dr.
Jarrod Mousa, a structural immunologist and HIV/AIDS Vaccine Scholars Program recipient, and Dr. Hai-Quan
Mao, a biomaterials and nanomedicine expert. Our findings have high potential to dramatically improve HIV Env
responses, and our findings will be applicable to the entire HIV vaccine field.

Public health relevance
The goal of this proposal is to determine if a nanoparticle (NP) platform that can direct antigens to the lymph nodes improves HIV vaccine responses in mouse and rabbit immunogenicity models. We will examine the utility of the NP platform to improve immune responses to germline targeting and stabilized HIV Env trimers and assess several immunological parameters. Our analysis of vaccine responses will determine if increased germinal center B cell responses and somatic hypermutation are observed in the context of the NP platform.